Cancer center support grant

Project Summary The Ohio State University Comprehensive Cancer Center ? Arthur G. James Cancer Hospital and Richard J. Solove Research Institute (OSUCCC – James) has been a NCI designated CCC since 1976. The OSUCCC mission remains to reduce cancer morbidity and mortality through continued basic, translational, population and clinical research. Eliminating disparities across the continuum of cancer care, with the inclusion of a diverse population in research, is vital to the development of new modalities to prevent, diagnose, and treat cancer. The OSUCCC is committed to providing the best care across the cancer continuum to all individuals who seek care at our facilities, which includes participation in research. One way to ensure that the population within the OSUCC-James catchment area receives best possible care is through engaging the various communities and providing cancer awareness, especially an understanding of the importance of trial participation. We will focus the proposed supplement on implementing a Clinical Trials Initiative within our urban underserved African American, low income Caucasian, Hispanic/Latino, Asian, and refugee (Somali and Nepali) communities, and an HPV Vaccination Initiative in all of these populations, as well as in our Appalachian and rural counties. To accomplish the goals of this NON supplement and build upon previous outreach efforts aimed at eliminating health disparities, OSUCCC will utilize two community health educators (1.2 total FTE) to work in partnership with researchers and key NCI-sponsored academic, and community, and regional partners to enhance NCI’s ability to effectively reach underserved and minority communities through achieving the following specific aims: Aim 1: Increase awareness and knowledge about clinical trials and biospecimen research and facilitate participation in clinical trials among racially/ethnically diverse communities in urban Columbus communities through implementation of Clinical Trial (CT) & Biospecimen Studies Participation Initiative; and Aim 2: Increase awareness and knowledge of the HPV types that can lead to cancer and uptake of the HPV vaccine in the various underserved populations in our catchment area through implementation of the Human Papillomavirus (HPV) Outreach and Vaccination initiative.

Public health relevance
PROJECT NARRATIVE The Ohio State University Comprehensive Cancer Center (OSUCCC) is a matrix cancer center that integrates and leverages all of the resources of the University to achieve its broad vision of creating a cancer free world. The OSUCCC addresses the public health needs of the catchment area (the state of Ohio) through research, education and community outreach and engagement as research conducted within the five OSUCCC Programs focuses on high priority cancers for the OSUCCC including lung, breast, colorectal, prostate, endometrial, cervical cancer, thyroid, and leukemia, as well as tobacco use, obesity and HPV vaccination. Screening and outreach activities are provided to the populations across the lifespan that we serve, especially those with higher burden of being diagnosd with cancer, such as racial/ethnic minorities and other underserved populations (e.g., rural, LGBTQ+, Appalachian) through targeted, culturally appropriate education activities, free cancer screenings, patient navigation, community networking, environmental scans, and addressing policy issues.